2022 Chemistry and Biology of Tetrapyrroles Gordon Research Conference

PROJECT SUMMARY
The Chemistry and Biology of Tetrapyrroles Gordon Research Conference (GRC) is the largest and broadest
international meeting for sharing and discussing the latest research on tetrapyrroles, a diverse group of protein
cofactors and metabolites which include heme, cobalamin (vitamin B12), chlorophyll, and bilins. Tetrapyrroles
serve as important cofactors to control essential cellular processes important for normal homeostasis and
development. In addition, tetrapyrroles also serve as a nutrient source and important signaling and regulatory
molecules in normal and disease states with broad implication on human health. This meeting serves as the
premier conference to present new unpublished tetrapyrrole related research findings; gather international
scientists at a variety of levels including senior scientists with early stage investigators (ESI) and trainees in both
formal and informal environments to create new connections and collaborations to advance the chemistry and
biology of tetrapyrroles; and provide and foster an inclusive environment for the development of diverse scientists
in an equitable and open setting.
The 2022 GRC meeting will be held from July 17 - 22, 2022 at Salve Regina University in Newport, RI. The
Chemistry & Biology of Tetrapyrroles GRC is one of a kind in terms of the international and diverse audience
that it attracts. The broad diversity of topics include clinical, biological, and chemical aspects of tetrapyrroles. In
addition, the range of organisms is equally as broad and spans from bacteria to humans. The 2022 GRC will
integrate research from a variety of researchers at different levels in the following areas: new structural
techniques to study tetrapyrroles; trafficking, signaling and regulation by heme; the many facets of bilins;
tetrapyrroles in human health and disease; the biology of tetrapyrroles; the many faces of B12; the regulation
and biosynthesis of chlorophyll pigments; and microbial tetrapyrrole metabolism. Given the critical roles that
tetrapyrroles play in pathogenesis of infectious disease, host immunity, normal cellular development and
metabolism, understanding the synthesis, regulation, degradation, and trafficking of tetrapyrroles is crucial for
human health.

Public health relevance
PROJECT NARRATIVE The 2022 Chemistry and Biology of Tetrapyrroles Gordon Research Conference (GRC) will bring together a diverse group of researchers with common interests in tetrapyrrole biology and chemistry. Tetrapyrroles are a group of cofactors and metabolites with broad and deep connection to human health including nutrition (macro- and micro-nutrients), normal cellular function and homeostasis (respiration, detoxication, protection from reactive oxygen species), disease states (porphyrias, anemias, infectious disease) and immunology (signaling via biliverdin, bilirubin, CO). The theme of the 2022 GRC is focused on the role of tetrapyrroles in these critical human health related processes and will have a significant impact on future research in the areas of infectious, immunologic and allergic, hematologic, neurologic, nutritional, liver, heart and kidney diseases.